Dopaminergic circuit modulation of learning and arousal-mediated memory enhancement

Project Summary
Learning and memory are modulated by dopaminergic circuits, which convey valence and/or arousal signals.
This proposal will examine how discrete dopaminergic circuits modulate learning and memory and neuronal
plasticity in memory-encoding brain regions in Drosophila. Specifically, it will disentangle the roles of
dopaminergic circuits that convey positive valence signals, negative valence signals, and valence-independent
arousal signals. In vivo imaging experiments will examine how these dopaminergic neurons drive discrete
patterns of plasticity in the mushroom body and downstream valence-coding output neurons that mediate
approach and avoidance behavior. Complementary behavioral and optogenetic manipulation experiments will
decipher how each of these neuronal subsets modulates arousal, valence, and memory strength. These
studies will apply the large genetic toolkit and experimental throughput of the fly toward developing a more
comprehensive understanding of how learning and memory alter the flow of information through the brain, to
ultimately engage novel behaviors (e.g., conditioned approach/avoidance) following learning.
Understanding how memories are encoded in the brain and disrupted in brain disorders is a prerequisite to the
rational design of treatments for memory impairment. Results of the present studies will provide guideposts for
future research into the molecular biology of memory formation across multiple model organisms, as
dopaminergic circuits regulate arousal and memory across taxa. The project will support our long-term goal of
understanding of memory down to the single-cell and subcellular levels, contributing to the knowledge base
necessary for the rational development of novel treatments for memory impairment.

Public health relevance
Project Narrative Memory impairment is a core deficit accompanying many neurological disorders. This proposal will examine how discrete dopaminergic neuronal subsets modulate memory, from the sub-cellular compartment through neuronal circuit levels. These experiments will add to the knowledge base required for rational design of treatments for memory disorders.